"Two year outcomes after dextrose gel prophylaxis for neonatal hypoglycaemia"

Abstract
Hypoglycemia (low blood glucose concentration) is common, and the only readily preventable cause of brain
damage in newborn babies. Approximately 1.2 million babies a year in the US are born at risk of hypoglycemia
and require regular blood tests to detect this problem. If hypoglycemia does occur, it is usually treated with
additional feeding, and if necessary admission to a newborn intensive care unit (NICU) for intravenous
glucose. Admission to NICU separates mothers and babies, interfering with the establishment of breast-
feeding, and is expensive.
Dextrose gel, rubbed inside the baby's cheek, is a simple, safe, inexpensive and effective treatment to reverse
neonatal hypoglycemia. A randomized trial of 2,129 babies is currently under way to determine whether
dextrose gel can be used to prevent hypoglycemia. Babies at risk of neonatal hypoglycemia are randomized to
dextrose or placebo gel prophylaxis. The primary outcome is admission to NICU.
If gel is effective in preventing hypoglycemia and admission to NICU, it may also prevent brain damage and
enhance breast-feeding. However, it is important to determine whether these effects, if they do eventuate,
have any beneficial effects on later developmental, health and growth outcomes. It is also important to be sure
that using gel for prevention is safe, in view of observational data that a rapid rise in blood glucose after birth
may be associated with poorer developmental outcomes.
This application is to follow up babies from the trial to determine if there are any benefits or adverse effects at
two years' corrected age. Assessments will include standardized measures of neurological status,
developmental status, executive function, vision and visual processing, physical size, general health, and
family environment.
Approximately 30% of babies are born at risk of hypoglycemia and hence may be eligible for dextrose gel
prophylaxis if it proves effective. This follow-up study will provide crucial evidence of longer term efficacy and
safety that will be essential before introduction into clinical practice.

Public health relevance
Project Narrative Approximately 30% of all babies, or 1.2 million babies a year in the US, are born at risk of hypoglycemia (low blood glucose concentration), which often requires admission to neonatal intensive care and can cause brain damage. This proposal is to follow up babies participating in a randomized trial of dextrose gel to prevent hypoglycemia1 to find out if there are any longer-term benefits or adverse effects at two years of age. This information will be essential to determine whether this simple, inexpensive and non-invasive approach to preventing a very common problem is effective and safe.